Translational Vision Science Research at Oregon Health & Science University

PROJECT SUMMARY
The premise of this proposal is that training the next generation of vision scientists in translation of basic science
research to clinical and public health interventions will be critical toward advancing the field. Basic scientific and
technological advances are occurring at an unprecedented pace. However, ophthalmologists often lack the
background to understand how recent basic and clinical research findings may be applied to their practices, and
basic scientists often lack adequate perspective to identify gaps in clinical knowledge to guide their research.
This application proposes to renew a successful T32 translational vision research training program for students
in pre-doctoral training programs in basic or applied science, or postdoctoral fellows at the Casey Eye Institute,
Oregon Health & Science University (OHSU). The overall goal is to prepare individuals for successful academic
careers in vision science research through didactic education and intensive mentored research experience in a
multidisciplinary environment. The vision research and training environment at OHSU is highly collaborative and
interdisciplinary, with strong programmatic support in translation of research from bench to bedside in areas such
as gene therapy, molecular genetics, clinical trials, ophthalmic imaging, and biomedical informatics. The
university has top educational programs in clinical ophthalmology and basic visual science, and is consistently
ranked in the top 10 nationally in NEI-supported research. This T32 program fills an important gap in education
because OHSU is one of the few major academic medical centers in the Pacific Northwest, yet there are no other
programs to support didactic training in visual science research here. We will continue to leverage the existing
infrastructure at OHSU to allow more pre-doctoral and post-doctoral trainees to benefit from and contribute
toward this research and educational environment. Since 2013, we have supported 21 trainees (including 3
under-represented groups, two first-generation college graduates and 4 women) who have published 88 peer-
reviewed papers (27 as 1st author) with their mentors in leading journals. All but one of our past trainees have
remained in science related careers, with the majority staying in vision research. Specifically, we propose to
continue this T32 program for 2 pre-doctoral and 1 post-doctoral trainee, which will be integrated with ongoing
research and existing OHSU graduate programs. Training consists of six key components: (1) research projects
with mentors and collaborators; (2) a didactic course covering fundamentals of basic, clinical, and translational
vision science; (3) monthly vision research seminars for discussion of ongoing research by trainees and faculty;
(4) institution-wide education and career development activities; (5) a grant mentorship program to teach and
support trainees as they apply for their own, independent funding; and (6) training in responsible conduct of
research. This T32 program continues to provide a clinical perspective to trainees with existing backgrounds in
basic science. OHSU is a setting where rigorous training through this T32 program will provide a generation of
young researchers with the tools to optimize translational vision research.

Public health relevance
PROJECT NARRATIVE Americans fear blindness more than virtually any other health problem. Approximately 14 million Americans, or approximately 6% of people aged 12 years and older, are visually-impaired. This will become an increasing clinical and public health problem as the population ages. Fundamental advances in science and technology have enormous promise for the treatment of eye disease. The premise of this proposal is to train the next generation of vision scientists in basic, clinical, and translational vision research to further our understanding of the underlying causes of ocular diseases and develop new clinical therapies for their treatment.